Origins of Skeletal Fragility in Type 1 Diabetes

Humans with type 1 diabetes mellitus (T1D) experience several disorders of skeletal health, including
decreased bone mineral density (BMD) and increased risk for fragility fractures (i.e., osteoporosis). These
features are the primary clinical characteristics of diabetic bone disease (DBD). Evidence suggests that DBD
occurs early in the progression of T1D; involves impaired bone formation; results in micro-architectural
abnormalities and poor bone matrix quality; and coincides with hyperglycemia and a decline in endogenous
insulin and insulin-like growth factor-1 production. While many have postulated that skeletal deficits in diabetes
occur as a direct result of glucose dysregulation, our pre-clinical studies in mouse models, supported by
observational studies in humans, show that impairment in the production and action of insulin and insulin-like
growth factor-1 (IGF-1) may be root causes of DBD. Specifically, our laboratory and others have demonstrated
that in rodent models of T1D: 1) deficits in bone formation occur in the context of insulin-deficiency; 2) near-
normalization of serum glucose alone is not sufficient to prevent DBD; 3) insulin and IGF-1 therapy improve
fracture resistance and new bone formation; and 4) both insulin and IGF-1 utilize similar down-stream
pathways to promote osteoblastogenesis and bone formation. To clarify the mechanisms and signaling
pathways by which insulin and/or IGF-1 modulate osteogenesis; to understand how deficiencies or impaired
signaling of each may contribute to DBD; and to delineate how each may contribute to therapeutic approaches
to prevent or treat DBD, we propose to 1) determine how insulin and IGF-1 deficiencies contribute to DBD at
the tissue, cellular, and molecular level, and 2) how each hormone may perform overlapping and independent
effects through specific downstream signaling pathways that may ultimately become therapeutic targets for
preventing and/or reversing DBD.

Public health relevance
Humans with Type 1 diabetes (T1D) are susceptible to diabetic bone disease and are more likely to suffer a fragility fracture than humans without T1D. Despite this now well-recognized increased risk of osteoporosis and fracture in persons with T1D, it is still not well understood how insulin, or its homolog, insulin-like growth factor 1 (IGF-1), directly affects skeletal well-being in this condition. The studies described in this project will define the relative contributions of insulin and IGF-1 to the molecular, cellular and tissue-level events involved in the development of diabetic bone disease, as well as explore the therapeutic potential of insulin and IGF-1 in preventing and treating diabetic bone disease.